Biomedical Informatics, Bioinformatics, and Cyberinfrastructure Enhancement Core

ABSTRACT – BIOMEDICAL INFORMATICS, BIOINFORMATICS, AND CYBERINFRASTRUCTURE ENHANCEMENT CORE The successful execution of clinical and translational research relies on coordinated access, curation, management, preservation, analysis, and dissemination of data, information, and knowledge from many sources (e.g., academic, health, and government). The long-term goal of the Advance-CTR Biomedical Informatics, Bioinformatics, and Cyberinfrastructure Enhancement (BIBCE) Core is to transform the environment for clinical and translational research in Rhode Island by enabling access to electronic health data, providing core informatics infrastructure, and identifying dissemination, implementation, and improvement strategies to overcome barriers to adoption of evidence into practice. Core activities are coordinated by the Brown Center for Biomedical Informatics, along with leadership from Advance-CTR partners (Brown University, The University of Rhode Island, Lifespan, Care New England, VA Providence Healthcare System, the Rhode Island Department of Health, and the Rhode Island Quality Institute). Through formal arrangements with our data partners, we have overcome barriers to accessing and sharing statewide data. The focus of the next phase of the BIBCE Core will be on establishing scalable resources and services for standardized and integrated access. Regular engagement of key stakeholders from the academic, health, and government communities has been critical as BIBCE Core resources and services are further enhanced to promote sustainability. The Core also seeks to train and engage researchers in best practices for applying resources, knowledge, and skills to support data- and technology- driven projects across the spectrum of basic, clinical, and population science. The mission of the BIBCE Core is thus to advance use of data and technology to support the full spectrum of clinical and translational research. The Specific Aims are to: (1) Promote a sustainable and extensible informatics infrastructure to support the diversity of clinical and translational research needs; (2) Develop innovative data, software, and technology solutions in collaboration with clinical and translational researchers; and, (3) Provide state-of-the-art informatics training and engagement with clinical and translational research stakeholders. Metrics for success to transform and invigorate clinical and translational research are aligned with national standards for evaluation as defined by the biomedical informatics community. Guided by the RE-AIM (Reach, Effectiveness, Adoption, Implementation, and Maintenance) framework and in collaboration with the Tracking and Evaluation Core, we will evaluate these outcomes, impacts, and metrics to gauge progress and success in meeting overall Advance-CTR objectives, including for our state’s health priorities. The continued engagement of Advance-CTR partners with the shared vision of using data and technology to improve the health of the State’s and regional population will synergistically expand clinical and translational research opportunities.